NEI UCI Center Core Grant for Vision Research

ABSTRACT
This P30 application seeks support for the Cores of Vision Research within the University of California
Irvine (UCI) that will strengthen and enhance NEI R01-funded research. The project also aims to support
the major expansion of vision research currently under way at UCI. It will broaden and optimize research
capabilities, support and expand existing research projects, and help establish new studies, ultimately
boosting productivity and strengthening vision research at UCI. Three research Core modules have been
identified that would provide substantial benefit to current and future NEI R01-funded projects at UCI: (i).
Ocular Microanatomy; (ii) Visual Function and Non-invasive Ocular Imaging; and (iii) Ocular Mass
Spectrometry, Lipidomics, and Proteomics. In addition, an Administrative Group will be established to
facilitate and support the function of these research Cores. The three research Cores were selected by
majority votes of all current NEI R01-funded investigators, and other investigators who are directly or
indirectly involved in ophthalmic research at UCI. The most requested services were developed into the
Cores described in this P30 application. The vision research community at UCI has grown significantly over the
past several years with the recruitment of 4 senior and 2 junior investigators and the formation of the Center for
Translational Vision Research (CTVR), with at least two more mid-career faculty recruitments in the works.
This expansion has been made possible by the exceptional institutional support from the Department of
Ophthalmology and the School of Medicine, who have committed significant financial and infrastructure
resources to bolster the vision research community at UCI. The services provided by the Cores for Vision
Research will meet the scientific needs of the NEI R01-funded researchers as well as of early-stage
investigators, and will increase efficiency, accelerate progress, and encourage new research directions
and scientific collaborations at UCI. The Cores will also provide training and access to state-of-the-art
experimental tools for students and postdoctoral scholars and will help prepare them for successful careers
in ocular research.

Public health relevance
NARRATIVE The present P30 application will provide research support for NEI R01-funded investigators and serve as a catalyst for the major expansion of vision research currently under way at the University of California Irvine (UCI). Our objective is to establish three research cores plus an administrative group that will advance the research programs of individual investigators by providing state-of-the-art facilities together with outstanding technical support by the Core Managers. The research cores are: 1. Ocular microanatomy, 2. Visual function and non-invasive ocular imaging, and 3. Ocular mass spectrometry, lipidomics, and proteomics.